Mechanisms of coordinated actin and microtubule dynamics

Project Summary/Abstract
The cytoskeleton consists of several filamentous proteins including actin filaments and microtubules, that
regulate nearly all vital cell processes including: cell division, morphogenesis, phagocytosis, and
movement/motility. Exactly how the activities of actin and microtubules are coordinated to carry out these cell
processes is not fully understood. The goal of this research is to determine how the dynamics of the actin and
microtubules are coordinated in two ways: 1) by a group of regulatory proteins that bind to actin and MTs and
also interact with each other: CLIP-170, mDia1, EB1, and IQGAP1; and 2) through the formation of disease-
relevant protein aggregates (liquid droplets). This project uses classical biochemistry and cell biology assays
combined with a unique 4-color advanced microscopy imaging system that permits the simultaneous monitoring
of purified actin and microtubules with fluorescently labeled single molecules of interacting proteins to illuminate
detailed molecular mechanisms. We will further test the physiological and disease-relevance of these
mechanisms during critical cell processes (i.e. cell division and migration) in several cell types. This research
will advance a dynamic and emerging field by defining complex molecular interactions and mechanisms of
microtubule-actin crosstalk that underlie a host of fundamental biological processes and neurological disease.

Public health relevance
Project Narrative These studies investigate the dynamic coordination between the actin and microtubule cytoskeletons through the individual and combined effects of several interacting proteins (CLIP-170, formin, EB1, and IQGAP1). We also investigate how the protein Profilin influences actin-microtubule crosstalk, and whether the formation of disease-relevant protein aggregates impacts cytoskeletal dynamics and/or organization. This research will provide new insights into the underlying mechanisms of several cancers and severe neurological disorders including Alzheimer’s and Huntington’s diseases, and amyotrophic lateral sclerosis (ALS).